Cancer Center Support Grant

DESCRIPTION (provided by applicant): The University of California San Francisco Helen Diller Family Comprehensive Cancer Center is an NCI-designed matrix center conducting a wide range of inter-disciplinary research in the areas of laboratory, clinical and population sciences integrating the activities of 179 members working at multiple campuses and hospital locations. Its goals are to: (1) support cancer research of the highest possible quality, in the areas of laboratory, clinical and population sciences; (2) develop patient outreach and education programs to increase the value of the Center to the local community; (3) promote and develop first-class care for cancer patients in our affiliated hospitals; and (4) create an integrated community of investigators dedicated to the shared goal of translating innovative science into improved clinical care. These goals are accomplished through the following 10 Programs and Shared Resources: Programs: Breast Oncology; Neurologic Oncology; Cancer, Immunity, and the Microenvironment; Prostate Cancer; Cancer Disparities; Hematopoietic Malignancies; Pediatric Malignancies; Cancer Genetics; Tobacco Control; Developmental Therapeutics. Shared Resources: Laboratory for Cell Analysis; Genome Analysis; Tissue; Immunohistochemistry & Molecular Pathology; Translational Informatics; Mouse Pathology; Preclinical Therapeutics; Computational Biology; Biostatistics; Clinical Research Support Office.

Public health relevance
The Helen Diller Family Comprehensive Cancer Center's goals are to: (1) support cancer research in the areas of laboratory, clinical and population sciences; (2) develop patient outreach and education programs; (3) promote and develop first-class care for cancer patients; and (4) create an integrated community of investigators dedicated to the shared goal of translating innovative science into improved clinical care.